Brain Changes in Pediatric Obstructive Sleep Apnea

PROJECT SUMMARY/ ABSTRACT
Pediatric obstructive sleep apnea (OSA) is a common and progressive syndrome accompanied by severe
cognition, mood, and daytime behavioral issues, as well as poor school performance, presumably stemming
from compromised neural tissue, induced by intermittent hypoxia and perfusion changes. However, it is unclear
whether the brain tissue injury is in acute or chronic condition, and whether myelin is preferentially affected than
axons, an essential step to understand, since interventions for neural repair/recovery differ for acute vs chronic
and myelin vs axonal injury. Also, it is unclear whether accompanying brain changes in pediatric OSA have
functional consequences, resulting to cognitive or mood deficits. In addition, intermittent hypoxia triggers a
cascade of injurious processes affecting endothelial cells, but unclear whether regional cerebral blood flow (CBF)
is reduced in pediatric OSA. Treatment methods for pediatric OSA include tonsillectomy and/or adenoidectomy,
and it is unclear whether brain tissue changes, regional CBF, and neural responses to cognitive challenge
improve post-treatment. Using diffusion tensor imaging (DTI) and diffusion kurtosis imaging (DKI)-based
procedures, acute and chronic tissue changes and axonal status and myelin integrity can be assessed. Regional
brain CBF can be assessed by validated arterial spin labeling (ASL) imaging, and regional neural activity to
cognitive challenge can be examined with blood-oxygen-level-dependent (BOLD) functional magnetic resonance
imaging (MRI). Thus, using 28 treatment-naïve, pediatric OSA and 28 control children, the specific aims are to;
determine the nature and types of brain tissue injury, using DTI and DKI measures, in untreated pediatric OSA
over healthy controls; identify regional brain CBF, using ASL imaging, and neural responses to cognitive
challenge, using BOLD functional MRI in pediatric OSA over healthy children; assess cognitive (by the differential
ability scale II and NEPSY II) and emotion functions (by the child behavior checklist) in pediatric OSA compared
to control children, and examine relationships between brain injury and cognitive and emotion dysfunctions in
pediatric OSA; and examine whether brain tissue changes, reduced CBF, and altered neural responses to
cognitive challenge reverse, and cognition and mood signs improve after adenotonsillectomy at 6 months in
pediatric OSA. In summary, the nature and types of brain injury, regional CBF changes, and neural responses
to cognitive challenge, and whether brain tissue changes, altered CBF, and diminished neural responses, as
well as mood and cognitive functions recover after adenotonsillectomy in pediatric OSA will be examined.
Evaluation of pathological characteristics is essential to assess the mechanisms of damage, and to suggest
intervention strategies before and after surgery. The findings will also help guide potential treatments to
rescue/restore brain tissue (e.g., nonsteroidal anti-inflammatory drugs) and improve CBF that could be
implemented to benefit cognitive and mood health, and improve academic performance in pediatric OSA.

Public health relevance
PROJECT NARRATIVE Pediatric obstructive sleep apnea (OSA) is a serious health issue, disrupting cognition, mood, daytime behaviors, and school performance, and is accompanied by brain changes in sites that regulate a range of these functions, but the nature (acute or chronic), types of tissue changes (axonal vs myelin), local cerebral blood flow status, and neural response to cognitive activity is unclear. We will use common and specialized magnetic resonance imaging procedures to determine the nature and types of tissue changes, regional cerebral blood flow, and neural responses to cognitive challenge, as well as examine the effect of surgery for breathing condition on brain tissue, cerebral blood flow, neural activity in cognitive control areas, and functions in pediatric OSA. The outcomes will have important implications for identifying potential effective treatments to rescue/restore brain tissue and improve cerebral blood flow that could benefit cognitive and mood health, as well as improve academic performance in pediatric OSA.